The Data Science Center for the Study of Surgery and Injury in Africa (D-SINE-Africa)

PROJECT SUMMARY/ABSTRACT
Trauma and other surgically treated conditions are a crippling, unaddressed burden of disease that disproportionately impacts sub-Saharan Africa (SSA) globally. The Data Science Center for the Study of Surgery, and Injury in Africa (D-SINE-Africa) is a strategic partnership between the University of Buea (Buea), the University of California (Los Angeles (UCLA) and Berkeley), the Cameroonian Ministry of Public Health, the African Institute for Mathematical Sciences in Cameroon, and the University of Cape Town in South Africa.
Although more abundant than ever, data is still a limited resource in low- and middle income countries. Our approach views “big data” available in SSA as an opportunity to develop sustainable data-constrained approaches appropriate for resource-constrained settings. Thus, data science will be harnessed to address our Hub’s two main goals which are; 1) to decrease the burden of injuries and surgical diseases through improved
surveillance, prevention, and treatment; and
2) to improve access to quality surgical care in Cameroon and other SSA countries.
These goals will be achieved through three specific aims:
1) Research 2) Networking and 3) Capacity Building. These aims are implemented through three cores (Administrative, Data Management and Analysis, and Capacity Building Cores) and two Research Projects that will be conducted in Cameroon, South Africa, and Uganda. Research Project 1 - Health Access Surveillance addresses the urgent gap in rapid
socioeconomic (SES) estimation necessary to track health access in acute care settings by applying a clustering algorithm to existing publicly available Demographic and Health Surveys data sets for SSA.
Research Project 2 – Trauma Follow Up Prediction aims to improve trauma outcomes by using machine learning to optimize a mobile phone-based screening survey that will identify which trauma patients would benefit from further care after they are discharged from the hospital, again using a data reduction “big data to small data” approach in line with the Hub’s commitment to sustainable data use practices. These projects utilize common data sources (Cameroon Trauma Registry), have harmonizing themes (injury, and data reduction), and will yield findings that can be used together (e.g., identification of SES groups vulnerable to poor follow up care). The Hub has innovatively built community engagement vehicles into the Internal Advisory Board to promote a multi-faceted approach to building trust with research participants and end-users. D-SINE Africa efforts will drive innovation and impact in data science and injury research to improve access to surgical
disease prevention and care, including those whose SES conspires to increase their vulnerability to injury and surgical conditions while reducing consistent surgical care access. D-SINE Africa’s strategic partners joint infrastructure are available for use by its members and DSI-Africa consortium at large.

Public health relevance
PUBLIC HEALTH RELEVANCE STATEMENT/ PROJECT NARRATIVE Trauma is the leading cause of death in the United States between the ages of five and 45 years, with a higher burden in rural “trauma deserts” or disaster-response settings where access to timely trauma care is resource-constrained. This US-Buea collaboration focuses on injury, leveraging data science to decrease the impact of trauma and surgical disease on the population of Cameroon and SSA by promoting collaborative research, networking, and capacity building in austere settings. These advances in trauma research and trauma care that will be made through this grant will be directly applicable to the United States population.